Wnt Signaling in Stroke

Project Summary
Wnt signaling in stroke
Intracerebral hemorrhage (ICH) is the most lethal but under-researched type of stroke. Therapeutic targets to
minimize pathologic processes focus on mitigating inflammation and promoting hematoma clearance. Wnt
signaling regulates diverse cellular activities and modulates an inflammatory response in microglia in certain
brain diseases. Although much work has investigated Wnt-dependent cell genesis, a critical gap exists with
respect to our understanding of how Wnt signaling regulates inflammatory responses after ICH. The secreted
frizzled-related protein 3 (sFRP3, a synonym of Frzb) regulates both canonical and noncanonical Wnt pathways,
and dysregulation of sFRP3 is associated with certain pathologic conditions, including osteoarthritis, astrocytoma,
and heart failure. However, very few studies have investigated sFRP3 in brain, and little is currently known about
the role of sFRP3/Wnt signaling in injury from stroke or ICH. The scientific objective of this R01 is to investigate
whether astrocyte sFRP3 inhibits proinflammatory response, thereby reducing acute ICH injury and improving
functional outcomes. By using multiple cellular, molecular, genetic, pharmacologic, histologic, and flow
cytometric methods, we have obtained strong evidence to suggest a key role for sFRP3 in protection against
early ICH injury: 1) sFRP3 expression level is upregulated in astrocytes in the perihematomal region early after
ICH; 2) Loss/gain of sFRP3 function exacerbates/mitigates ICH injury; and 3) sFRP3 deletion increases
expression of Toll-like receptor (TLR)4 and Wnt downstream molecule RhoA, as well as MMP-9 activity in the
ICH brain. These novel observations support the scientific premise that astrocyte sFRP3 protects against early
ICH injury and led us to hypothesize that astrocyte sFRP3 promotes microglial M2 polarization through inhibition
of TLR4 signaling and that astrocyte sFRP3 attenuates brain damage through TLR4/Wnt signaling after ICH. In
three specific aims, we will determine whether loss/gain of sFRP3 function exacerbates/mitigates ICH injury (Aim
1), whether astrocyte sFRP3 promotes microglial M2 polarization through inhibition of TLR4 signaling (Aim 2),
and whether astrocyte sFRP3 attenuates brain injury through the TLR4/Wnt signaling pathway (Aim 3). Using
multidisciplinary approaches, this study will elucidate the role of astrocyte sFRP3 after ICH and the cellular and
molecular mechanisms by which astrocyte sFRP3-mediated microglial phenotypic switching mitigates gray and
white matter injury, and improves functional recovery. This novel proof-of-concept work has translational potential
and will stimulate more studies of sFRP3 in various brain diseases. Investigating innate immunity after stroke is
a critical priority identified by the recent NINDS-SPRG.

Public health relevance
PROJECT NARRATIVE The secreted frizzled-related protein 3 (sFRP3) regulates a signaling pathway that might cause inflammation when activated in brain cells known as microglia. We will investigate whether sFRP3 produced in another type of brain cell, the astrocytes, enhances the beneficial activities of microglia and thereby improves outcomes of mice with brain hemorrhage. We will attempt to understand the underlying cellular and molecular mechanisms by which astrocyte sFRP3 acts on the hemorrhagic brain.